TRAINING PROGRAM IN THE NEUROBIOLOGY OF DRUG ABUSE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. This training grant in the neurobiology of drug abuse continues to support four predoctoral students and six postdoctural fellows after their second year when they make a commitment to work in a lab on a drug abuse problem. The training assignment is with approved faculty listed above using a variety of molecular, neurochemical, anatomical, behavioral or genetic approaches. This is the final year of this training program.